Improving Mucosal Melanoma Therapy by Harnessing the Immunogenicity of r3LCMV

Abstract/Summary
Viral-based cancer therapies for cancer exert powerful antitumoral effects both through direct infection and lysis
of tumor cells and by triggering immune responses against the tumor. Currently FDA approved oncolytic viruses
are targeting melanoma and bladder cancer, and there is a growing list of viral agents on the horizon. However,
current viral-based therapies have limitations in terms of their safety and efficacy, warranting development of
novel agents. It has been suggested that an arenavirus like lymphocytic choriomeningitis virus (LCMV) could be
attenuated to render it ideal for viral therapy against cancer. In this proposal, we demonstrate the powerful anti-
tumor activity of a highly attenuated LCMV strain, r3LCMV. Engineered from LCMV, this virus is exceptionally
immunogenic in mice and humans, and r3LCMV vectors expressing HPV antigens are already being clinically
tested as a cancer vaccine. However, our data from multiple murine tumor models, including melanoma models,
suggests that r3LCMV is exceptionally effective intratumorally (IT) even without expressing tumor antigens. Our
group has been developing novel immunotherapies for melanoma with a focus on mucosal melanoma (MM), a
particularly deadly melanoma variant of the mucosal surfaces. MM has one of the best immunocompetent
models there is: the spontaneous oral MM tumors that occur naturally in pet (companion) dogs. This project will
have 2 aims, each evaluating different aspect of this therapy and exploring different clinical settings:
Aim 1: To determine whether neoadjuvant r3LCMV treatment improves disease-free survival (DFS) in
dogs with naturally occurring MM. We will launch a placebo controlled veterinary trial to evaluate the effect
of IT r3LCMV administration in the neoadjuvant setting for dogs diagnosed with MM.
Aim 2: To utilize r3LCMV to improve cellular therapy of MM. TIL generated from canine MM tumors treated
with r3LCMV or placebo will be compared for phenotype, ex-vivo function and clinical efficacy for the treatment
of metastatic disease.

Public health relevance
NARRATIVE Our recent data elucidates powerful anti-tumoral effects by a novel viral vector therapy, based on an attenuated form lymphocytic choriomeningitis virus (LCMV). Through a collaborative effort across multiple principal investigators, we aim to harness the immunostimulatory potential of this therapy in preclinical studies focused on pet dogs who have naturally developed mucosal melanoma. If successful, this project will enable rapid translation into clinical trials for patients with this terrible cancer and has the potential to broadly impact cancer therapy using viral agents.